Advancing functional mass spectrometry imaging methodology to monitor dynamic physiological processes

PROJECT SUMMARY
Spatially resolved ‘omics techniques have been instrumental in describing the heterogeneity in molecular content
in tissues. However, these methods can only provide static measures of the variation in content and fall short on
relating how this molecular heterogeneity results in differences in tissue function. Our laboratories have
developed a unique functional Mass Spectrometry Imaging (fMSI) method that can measure tissue perfusion
and metabolic activities at high spatial resolution and can provide a critical link between spatially resolved ‘omics
data and cellular phenotype. This fMSI method uses timed infusions of isotopologues of a single substrate prior
to tissue harvest to obtain dynamic data at each sampled location. We demonstrated the feasibility of this method
to detect uptake (perfusion) of isotopologues of glycine and their conversion to glutathione in liver and tumor
tissue but there remain significant challenges to realizing the full potential of this method. This project is centered
around four aims. Aim 1 will evaluate different bolus and constant infusions protocols for isotopologue
administration with the objective to improve the sensitivity and extend the observable metabolic window. Aim 2
will administer isotopologues of pimonidazole and urea to demonstrate that fMSI can detect oxygenation and
perfusion dynamics in tissues. Aim 3 will demonstrate the general utility of the fMSI method to measure pentose
phosphate pathway activity in tissues. Aim 4 will tie together the fMSI data to generate spatially-specific
mathematical models of tissue metabolism and validate in vivo observations of the effect of microenvironmental
variations on metabolism using in vitro perfusion models. Successful completion of these Aims will position fMSI
as a unique bioanalytical tool to provide high spatially resolved functional data in any tissue sample.

Public health relevance
RELEVANCE TO PUBLIC HEALTH A new functional imaging method will be developed to characterize metabolic activity variations across healthy organs and tumor tissue. Functional imaging can be used to identify therapeutic targets in human disease.